A Histamine Pharmacodynamic Biomarker to Guide Treatment in Pediatric Asthma

Project Summary
The overarching goal of the parent award is to validate the Histamine Iontophoresis with Laser Doppler (HILD)
flowimetry biomarker for prediction of treatment response to Levocetirizine among children with asthma. This
research supplement will support both aims of the parent award as the parent award primary research
activities include the conduct of a large clinical trial in children. Completion of safe and efficient clinical trials in
children is essential for pediatric drug development. Over 20% of pediatric clinical trials fail or are discontinued
early due to lack of enrollment and over 30% of trials do not meet initially defined recruitment goals. Barriers to
participant recruitment and retention within pediatric clinical trials must be examined and addressed to increase
the number of successful trials and the dissemination of important pediatric dosing, safety, and efficacy
information. Overall, there is a lack of evidence-based strategies for pediatric trial recruitment and retention.
We will address this gap, utilizing data from a real-world pediatric clinical trial. This supplement supports the
success of future pediatric clinical trials by addressing three key areas. We will 1) compare the efficacy of three
strategies for recruiting and retaining participants in pediatric clinical trials; 2) determine whether the efficacy of
recruitment and retention strategies differs between Black/ African American children and White children; and
3) provide Ms. Ikerionwu with training and foundational knowledge in the conduct of pediatric clinical trials that
supports her development as an aspiring physician-researcher conducting pediatric clinical trials. The
objective of this application is to determine the most effective and efficient methods for enrolling and
retaining children in a double blinded, placebo controlled clinical trial. We hypothesize that there will be
superior strategies identified for pediatric participant recruitment and retention. This will be accomplished by
Aim I to determine the most effective recruitment strategies for pediatric clinical trials. We hypothesize
that differences exist in recruitment effectiveness between enrollment by face-to-face contact in clinical
settings, tele-recruitment based on patients lists, and community partnership strategies and that face-to-face
recruitment strategies within the clinical settings will have increased efficiency and effectiveness. In Aim II, we
will determine barriers to retention in pediatric clinical trials. In both aims we will also determine
differences in effective recruitment and retention strategies between children who identify as White/ Caucasian
in comparison to children who identify as Black/ African American. The proposed work in this application will
provide foundational knowledge and skills in the conduct of pediatric clinical trials and clinical research by a
junior investigator from an under-represented background, thus leading to a future career as a physician
scientist. The work will also provide evidenced based knowledge to inform successful recruitment and retention
in diverse pediatric clinical trials.

Public health relevance
Project Narrative Over 20% of pediatric clinical trials fail or are discontinued early due to lack of enrollment and over 30% of trials do not meet initially defined recruitment goals. This limits the ability to conduct pediatric trials that lead to safe and effective therapeutics for use in children. We will determine the most effective methods of recruitment and retention of children and families in a therapeutic clinical trial.